Institutional Training Grant in the Genomic Sciences

Abstract

The Genomic Sciences Training Program (GSTP) is building the new generation of genomic scientists
with strengths spanning across multiple disciplines. The training opportunities and environment we
propose will enable our trainees to create and apply new tools, derived from technological advances
that are informed by cutting-­edge statistical and computational approaches that functionalize diverse
and large datasets. The new genomic approaches to biological and medical investigation demand
scientists who are knowledgeable and skilled across several fields in effective ways that potentiate new
insights or inventions. Accordingly, the emergence of new tools allowing for the creation and
interpretation of large-­scale experimental efforts is what GSTP has focused on by the didactical
interweaving of investigative approaches drawn from multiple fields (biology, genetics, physical
sciences, engineering, computer science, and statistics) that were individually contoured for
complementing a trainee’s core disciplinary focus, yet built upon achievement and knowledge within the
genomic sciences. Given the incredibly rich scientific and engineering breadth of the University of
Wisconsin, GSTP has been able to recruit outstanding trainees who greatly advanced mass
spectroscopy, “omic”-­integration, computation, artificial transcription factors, and bio-­devices, while
exploring new applications leveraging these advantages for cutting-­edge investigation into proteomics,
transcription, metabolomics, and genome biology. These achievements and contributions have
nucleated and grown a significant genomics community. This genomics community has become a
gateway and central hub for groundbreaking collaborations reaching across departments, centers,
schools and other training programs. We propose for the upcoming project period that we continue this
focus, with added emphasis on innovation/invention and fostering of clinical applications, which will
advance Precision Medicine. We request funding for 10 predoctoral and 4 postdoctoral traineeships per
year. In the next funding period we will continue to recruit and train trainees who have recently
completed their undergraduate or graduate degrees.

Public health relevance
Project Narrative Modern medical practice is now relying on the fruits of genomic research for analyzing the genetic makeup of patients and their cancers. New medical treatments are increasingly being tailored to individual patients for increasing their effectiveness and lessening side- effects. We propose to train scientists who will be developing the systems and analysis that will enable greater use of genomic information for biomedical researchers and the general public when they see a doctor.